Investigating the source and the action behind shunt obstruction in the treatment of pediatric hydrocephalus

PROJECT SUMMARY
Hydrocephalus, an imbalance between cerebrospinal fluid production and absorption, is diagnosed in
more than 1 in 500 people in the United States. Approximately 80% of these patients will suffer long-term
neurological deficits. Genetic diseases, meningitis, subarachnoid hemorrhage, stroke, traumatic brain injury, or
tumors cause hydrocephalus. The common treatment for all hydrocephalus patients is CSF drainage by
shunting. Despite all our efforts, shunts still have the highest failure rate of any neurological device. A
shocking 85% of shunts fail after just ten years. Failed shunts are plagued with astrocytes and macrophages,
but we still do not understand the process by which these cells are pulled in, migrate, and grow.
In our first aim, we identify what patient conditions contribute to tissue contact and what variables
trigger tissue pull in into shunt catheter holes. We clearly define physical variables that create instances of
tissue pull in using computational fluid dynamics and a benchtop model (“Brain on a Bench”). We continue the
use of this system in Aims 2 and 3. In this way, we investigate what single or repetitive events cause shunt
catheter contact and tissue pull in with the ventricular wall, parenchyma, or choroid plexus.
In our second aim, we determine if cell growth is a necessary component to shunt obstruction after
contact with a tissue source occurs. We examine the growth, proliferation, and activation state of the cells
following single or repetitive contact with ventricular wall, parenchyma, and choroid plexus just as we did in
Aim 1.
In our final aim, we use our heightened awareness of tissue pull in and tissue growth to understand
how changes to shunt design can influence shunt obstruction. We prioritize the clinical conditions shown to
exacerbate tissue contact and test under physical variables that show direct pull in and growth of ventricular
wall, parenchyma, and choroid plexus.
In summary: our patient data informs us of the patient conditions that correlate to contact of ventricular
wall, parenchyma, and choroid plexus. Benchtop and computational fluid dynamics models prioritize these
environmental conditions while systematically testing what variables cause tissue pull in and growth. Strategies
to prevent obstruction by inhibition of pull in and growth are tailored for ideal performance under the conditions
set by our patient and benchtop data. Altogether, these data improve our mechanistic understanding of shunt
obstruction necessary to and narrow our area of focus for improved treatment of hydrocephalus.

Public health relevance
PROJECT NARRATIVE Hydrocephalus is a disorder causing excess accumulation of cerebrospinal fluid in the brain, treated by using shunts to divert cerebrospinal fluid out of the cranial cavity. Our team of bioengineers, neurosurgeons, and experts in neurophysiology and biostatistics will identify patient subpopulations which correlate with a high degree of contact between the shunt catheter and tissue; then, we identify the conditions in which cause obstruction by this tissue being mechanically pulled in or biochemically grown in. By studying correlations in the patient population and causations using a benchtop model, we embrace a multi-disciplinary approach that will provide a better understanding of the mechanisms leading to shunt failure so that we can inhibit that response from occuring.